The cohesin complex as a tumor suppressor in myeloid leukemia

ABSTRACT Acute myeloid leukemia (AML) is the most common adult leukemia characterized by excessive proliferation of abnormal myeloid progenitors. AML continues to have a dismal survival rate amongst all subtypes of leukemia (<50% five-year overall survival rate), which can largely be attributed to limited advances in treatment regimens that, for the last decades, have relied on the use of two non-targeted cytotoxic drugs: cytarabine and anthracycline. Large-scale sequencing efforts have shed new light on genetic and epigenetic determinants of AML. Interestingly, these studies identified a frequent co-occurrence of somatic mutation between genes encoding cohesin complex subunits (such as STAG2, SMC1A, RAD21 and SMC3) and well-characterized AML oncogenic triggers, such as FLT3-ITD, TET2, and NPM1. Recent work has demonstrated an important role for the cohesin complex in normal stem/progenitor self-renewal and differentiation, gene regulation, and suppression of myeloproliferative neoplasms and AML, despite the precise mechanisms underlying these functions remaining poorly understood. It is believed that cohesin may suppress tumor formation by regulating chromatin looping at loci critical for self-renewal and myeloid progenitor differentiation. Utilizing established models of murine and human AML, this application focuses on the molecular mechanisms of cohesin- dependent myeloid tumor-suppression, with an emphasis on understanding novel treatment approaches that can exploit these functions. Using established protocols for identifying genome-wide changes in chromatin topology and gene expression, we propose to undertake an extensive characterization of cohesin-regulated chromatin changes driving AML. Furthermore, recent studies have identified inhibition of HDAC8 and poly-ADP ribose polymerase (PARP) as an attractive targeted treatment approach for cohesin-mutated AML patients. Here we investigate the application of targeted agents in cohesin-deficient AML whilst extensively mapping the mechanisms-of-action underlying these specific treatments. Ultimately, this project aims to generate novel, pre- clinical disease models of cohesin-mutated AML with strong mechanistic insights into the tumor-suppressive function of this complex.

Public health relevance
NARRATIVE This project aims to generate novel, pre-clinical disease models of cohesin-mutated AML that will let us gain strong mechanistic insights into the tumor-suppressive function of this protein complex that is frequently mutated in this disease.